Administrative Core

Core A: Administrative Core SUMMARY/ ABSTRACT
The overall goal of the MD Anderson Cancer Center SPORE in Ovarian Cancer is to translate high-quality research
into improved clinical outcomes for women with ovarian cancer. To ensure the success of the SPORE, the
Administrative Core will provide effective management and administration of all activities relating to each project,
core, career enhancement and developmental program in the SPORE. The Administrative Core will communicate
and disseminate information between our SPORE investigators and facilitate information sharing and collaborations
with other SPOREs and external collaborators. The Core will provide a platform for integrating diverse scientific
disciplines into a unified multidisciplinary approach for achieving excellence in translational ovarian cancer
research. The Administrative Core will monitor timelines and ensure both basic science and clinical trial aims are
met for all SPORE projects. Co-Core Directors and MPIs, Drs. Anil Sood and Robert Bast, along with Ovarian
SPORE Administrator, Ms. Ersulan Hampton and Ovarian SPORE Scientific Writer, Dr. Robert Langley, will direct
the objectives of the Administrative Core. The objectives of the Core are to: 1) direct the planning and evaluation to
ensure the overall scientific quality and strategic direction of the SPORE; 2) manage all fiscal and budgetary issues
across all Projects, Cores and Developmental Research and Career Enhancement Programs; 3) monitor the data
sharing compliance of the SPORE to adhere to all general governmental and specific NCI regulations and
requirements; 4) coordinate quality assurance activities, including data quality controls with support from the
Bioinformatics and Biostatistics Core and the Pathology Core; 5) serve as the communication hub for the SPORE
to provide up-to-date operating information to investigators; 6) communicate and confer with the NCI Project Officer
and other staff to make certain all necessary reporting requirements are met, including PMCID policy compliance;
7) coordinate the annual process for selection of Developmental Research and Career Enhancement Program
recipients, and establish policies and procedures that result in the successful recruitment of women and
underrepresented minorities to these programs and ensure awardees are supported with outstanding mentorship;
8) ensure the SPORE is integrated in administrative organization of the institution; 9) initiate and coordinate inter-
SPORE and inter-institutional interactions and seminars; 10) facilitate resolution of scientific disputes; and 11)
organize and maintain patient advocate involvement in the SPORE.